The role of obscurin and Obsl1 as key determinants for diastolic function

Project Summary: The role of obscurin and Obsl1 as key determinants for diastolic function
Cardiovascular disease (CVD) remains a leading cause of mortality in the US, with heart failure
accounting for nearly 10% of CVD-related deaths in 2015. Heart Failure with preserved Ejection
Fraction (HFpEF) is responsible for half of heart failure hospital admissions, thereby presenting
a major health and socioeconomic problem. The diagnosis and development of treatment
options for HFpEF remains challenging, due to the diverse patient population, and the high
prevalence of heterogenous comorbidities, such as diabetes, obesity or hypertension. Several
pathomechanisms have been suggested to play major roles in the development of the disease.
However, the dearth of pre-clinical animal models and cardiac patient biopsies that allow for
proper characterization of the syndrome complicates the search for molecular pathways and
pathomechanisms.
We identiﬁed that mice lacking obscurin and the closely related obscurin-like 1 (Obsl1) die
prematurely and suﬀer from diastolic dysfunction, a key feature of HFpEF. Based on
preliminary data from this novel genetic disease model, we hypothesize that functional
insuﬃciency of the sarcoplasmic reticulum in combination with mitochondrial impairment found
in these mice, results in diastolic dysfunction. In this proposal, we aim to establish how loss of
obscurin/Obsl1 alters cardiac physiology, metabolism and calcium cycling. Of special interest
are novel Obsl1 interaction partners that directly tie functions of this protein to mitochondrial
impairment on the molecular level. We will also test if there is a gender divergence in the
susceptibility for this disease, as epidemiological HFpEF studies suggest. Outcomes from this
project will also determine metabolic and mitochondrial changes in the obscurin/Obsl1 double
knockout model that are associated with heart failure development. Finally, we will test if
overexpression of Perm1, a master regulator of mitochondrial biogenesis and function is able
to alleviate diastolic dysfunction development.
Results from this study are expected to establish molecular roles for obscurin/Obsl1
insuﬃciency in the etiology of diastolic dysfunction and HFpEF, and determine molecular
targets for the development of novel therapeutics to treat the disease.

Public health relevance
Project Narrative: The role of obscurin and Obsl1 as key determinants for diastolic function This project investigates molecular determinants for the development of heart failure with preserved ejection fraction (HFpEF), a disease that accounts for approximately 50% of heart failure hospital admissions in the US. Mice that lack obscurin/Obsl1 die prematurely and develop diastolic dysfunction, a key pathogenic feature of HFpEF. Using this novel genetic model of diastolic dysfunction, we aim to uncover novel mechanistic roles of obscurin/Obsl1 for mitochondrial function, their inﬂuence on the cardiac metabolism, and on sarcoplasmic reticulum proteins that determine cardiac calcium cycling.